CCR-Frederick Flow Cytometry Core

To date in FY2023, the Core has performed 230 billable services, including 522 individual samples sorted and 1024 hours billed. The core's cytometers were used for 1454 sessions totaling more than 4300 hours. The Core recorded 90 unique users from numerous CCR labs and NIH programs, including the Cancer Innovation Laboratory, Mouse Cancer Genetics Program, Chemical Biology Laboratory, RNA Biology Laboratory, Cancer & Developmental Biology Laboratory, Center for Structural Biology, Laboratory of Cell & Developmental Signaling, Vaccine Branch, FNL Molecular Targets Lab, Collaborative Clinical Research Branch (NIAID), and the Office of the Clinical Director. The core trained 14 new users (scientists, fellows, students and technicians) from 6 different labs to use flow cytometry in their work. To keep up with evolving cytometry technology and ensure uninterrupted service as old instruments become obsolete, core staff evaluates new instruments and software, and meets regularly with flow facility leaders across NCI to harmonize instrument offerings and secure favorable pricing for equipment and service maintenance agreements. The core organized technology presentations highlighting using cytometry in RNAseq workflows by BioLegend and 10X Genomics (Jun 2023) and advances in spectral cytometry by Thermo (Nov2022) and microfluidic cell sorting by Miltenyi (May 2023). Core staff attended the Congress for the International Society for the Advancement of Cytometry (CYTO, May 2023) and Automated Flow Solutions showcase (Montgomery College, Oct 2022). The core was acknowledged for technical contributions to these 2022/2023 publications: 1) IL-27 induces an IFN-like signature in murine macrophages which in turn modulate colonic epithelium. Andrews C, et al. Front Immunol 14: 1021824 (2023) PMID 37153622 2) Co-Culture and Transduction of Murine Thymocytes on Delta-Like 4-Expressing Stromal Cells to Study Oncogenes in T-Cell Leukemia. Rodrigues et al. J Vis Exp 196 (2023) PMID 37358271 3) Selective Recognition of Carbohydrate Antigens by Germline Antibodies Isolated from AID Knockout Mice. DeLaitsch et al. J. Am. Chem. Soc, 144: 4925 (2022) PMID 35282679 4) An engineered cell line with a hRpn1-attached handle to isolate proteasomes. Negi et al. J. Biol. Chem. 299(8): 104948 (2023) PMID 37354974 5) IFN-γ and androgens disrupt mitochondrial function in murine myocytes. Fenimore et al. J Pathol 260: 276-288 (2023) PMID 37185821 6) Method To Diversify Cyanine Chromophore Functionality Enables Improved Biomolecule Tracking and Intracellular Imaging. Usama et al. J. Am. Chem. Soc. 145:14647 (2023) PMID 37367935 7) Cyanine Masking: A Strategy to Test Functional Group Effects on Antibody Conjugate Targeting. Thapaliya et al. Bioconjugate Chem. 33: 718 (2022) PMID 35389618 8) Stabilization of E-cadherin adhesions by COX-2/GSK3beta signaling is a targetable pathway in metastatic breast cancer. Balamurugan et al. JCI Insight 8(6):e156057 (2023) PMID 36757813. The core manager presented a flow cytometry lecture as invited speaker to Hood College Molecular Immunology class BMS 539 (Nov2022), and also published an in memorium essay about cytometry pioneer Howard Shapiro in Critical Values (published by American Society of Clin Pathology Sep2022).